Predoctoral Training of Neuroscientists

Project Summary
This proposal is for a competitive renewal of the NS105604 training grant under the Jointly Sponsored NIH
Predoctoral Training Program in the Neurosciences (JSPTPN) at the University of Minnesota. The program
has been very successful over the last five years, setting 32 predoctoral trainees on the start of their
graduate career. It continues the University of Minnesota’s highly successful NIGMS training program,
“Predoctoral Training of Neuroscientists” (T32-GM08471,1993-2018) under the Systems and Integrative
Biology Program. Trainees in this program are pursuing a PhD through the Graduate Program in
Neuroscience at the University of Minnesota, an interdepartmental and interdisciplinary program that spans
30 departments. This proposed program provides select trainees added value in the first two years of their
graduate careers, providing its trainees with a broad foundation in neuroscience as well as the
interdisciplinary skills needed to be successful within their neuroscientific careers. In particular, the program
is designed to provide a broad understanding of the field as well as a deep understanding of research
methodologies, experimental design, and quantitative reasoning. This program is built around a core of
didactic coursework in neuroscience, exposure to research-related issues such as ensuring rigor and
reproducibility and quantitative analyses, and the beginning of thesis-related in-depth research projects.
Flexibility and time for in-depth development of collateral fields of knowledge are provided. Several unique
educational opportunities are included, including the long-running Itasca summer laboratory, rotations, and
specific classes in rigor, reproducibility, and quantitative reasoning. Time and attention are given to the
student’s professional development, including exposure to neuroscience at the national and international
levels. A talented group of trainers have been assembled that reflects the diversity of research questions,
areas of study, and techniques in neuroscience. Each trainer directs a productive research program and
has demonstrated commitment to teaching and training. The trainers are united by their participation in the
Graduate Program in Neuroscience and by their dedication to predoctoral training. An impressive array of
scientific and institutional resources are available to the trainees, including substantial direct institutional
support for this training grant. The graduates of this program will be trained to be independent researchers,
capable of making contributions in academia, teaching, industry, government, and public service.

Public health relevance
Project Narrative Success in the field of neuroscience requires a broad understanding of the field as well as a deep understanding of research methodologies, experimental design, and quantitative reasoning. This program will provide its trainees with a broad foundation in neuroscience as well as the interdisciplinary skills needed to be successful within their neuroscientific careers. The students will be trained to be independent researchers, capable of making contributions in academia, teaching, industry, government, and public service.